Dual Sensory Loss: Impact of Vision and Hearing Impairment on Spatial Localization

1 Project Summary/Abstract
2 Dual Sensory Loss (DSL) is the co-occurrence of vision and hearing loss. The prevalence of DSL rises
3 steeply with age and is expected to increase as the American population ages. People with DSL have increased
4 difficulties in daily functioning, because many real-life tasks require both vision and hearing. Despite extensive
5 attention to the rehabilitation for vision and hearing loss separately, very little attention has been paid to the
6 specific challenges faced by people with DSL. The candidate’s long term goal is to improve the quality of life and
7 independence of people with DSL by optimizing the utilization of their residual vision and hearing. The current
8 study focuses on their spatial localization. Spatial localization refers to determining the direction of sounds and
9 visual objects in the environment, and it is important for safe mobility and effective social interaction.
10 In the K99 phase, the candidate’s goal is to investigate the impacts of vision and hearing deficits, both
11 individually and in combination, on the spatial localization of people with DSL, and to establish a spatial
12 “perimetry” measure to characterize these effects. In a controlled laboratory context (Aim 1), the candidate plans
13 to measure the localization perimetry of subjects with DSL, in each of the visual, auditory, and audiovisual
14 conditions. The candidate will then measure subjects’ localization ability in two simulated real-life tasks (Aim 2):
15 localizing a car that is about to move in a parking lot and understanding a speaker among a group of people.
16 The findings in Aim 1 will be verified in these ecologically relevant mobility and social contexts in Aim 2.
17 In the R00 phase, the candidate’s goal is to develop and evaluate training methods that can improve the
18 spatial localization ability of people with DSL. The candidate proposes that a training plan needs to be tailored
19 based on the evaluation of the individual’s spatial localization ability. A recalibration training method is developed
20 with the purposes of re-establishing congruent visual and auditory space perception, and facilitating audiovisual
21 combination to maximize the use of residual vision and hearing.
22 The K99 phase will take place in the University of Minnesota, where the candidate will be jointly mentored
23 by Dr. Gordon Legge who specializes in low-vision research, Dr. Peggy Nelson who specializes in hearing-loss
24 research, and Dr. Dan Kersten who specializes in computational vision science. The candidate will also receive
25 excellent advice in auditory perception from Dr. Andrew Oxenham, in ophthalmology from Dr. Erik van Kuijk and
26 in audiology from Dr. Evelyn Davies-Venn. The training plan is to extend the candidate’s knowledge in
27 translational vision and hearing science, the techniques of multisensory modelling, the pathology of vision and
28 hearing impairment, and the contemporary strategies of assessment and rehabilitation. With successful training,
29 the candidate will independently conduct the studies in the R00 phase. The candidate’s career goal is to lead a
30 research team to improve the life quality and independence of people with DSL.

Public health relevance
Project Narrative People with both vision and hearing loss have increased difficulties in daily functioning. Very little attention has been paid to the rehabilitation challenges faced by this large and increasing population. This project will investigate the impact of combined vision and hearing loss on the difficulties of this group in spatial localization, that is, in the ability to determine the direction of sounds and sights of objects in the environment.